Cardiovascular risk factors and preterm delivery

DESCRIPTION (provided by applicant): Preterm delivery, defined as birth occurring prior to 37 completed weeks'gestation, complicates 12-13% of all births in the United States. For reasons that are largely unknown, the rate of preterm delivery has increased during the past few decades. Preterm delivery is not only a leading cause of neonatal morbidity and mortality but also has long-term sequelae for the offspring. Limited data suggest that there is also consequences for the mother - factors related to cardiovascular risk may increase the rate of preterm delivery during the mother's reproductive life and cardiovascular morbidity and mortality in the mother's later life. Whether or not the association is replicable and persistent is unclear and the nature of the underlying mechanism (s) is not understood. We propose to conduct a nested case-control study to examine whether several major cardiovascular disease (CVD) risk factors (hyperlipidemia, biomarkers of inflammation and endothelial dysfunction) are associated with an increased risk of preterm delivery and whether abnormal levels of CVD risk factors persist at 6 weeks postpartum. We will compare all measurements from cases (women who delivered preterm) to controls (randomly selected from among women who delivered at term) between early and late pregnancy and postpartum. We will use already collected data and specimens (fasting blood samples collected at entry to care (<20 weeks), week 28 gestation and 6 weeks postpartum) in our prospective studies of low income, minority women from Camden New Jersey (N=2,816 enrolled 1996-2006). We hypothesize that in comparison to controls: 1). Biomarkers for CVD risk are elevated in the cases either early in gestation or become elevated later in pregnancy;2). Biomarkers for CVD risk remain elevated in cases during the postpartum. Our data have the potential to provide important insight into the mechanisms underlying preterm delivery and later CVD risk in women who deliver preterm. Our long term goal is to determine if women who delivered preterm have eventual evidence of CVD risk or CVD events by following Camden study participants who delivered 2-25 years ago. Thus, this research has important implications for child health and for women's health during the reproductive and the mature years.

Public health relevance
PUBLIC HEALTH RELEVANCE: Infants born preterm are at high risk of infant death and of serious complications that carry a high cost to society. Women with a history of preterm delivery may also be at risk of cardiovascular disease (CVD) in later life. Preterm delivery and/or later CVD may be preventable by screening for CVD risk factors, many of which (e.g. high lipid levels) are potentially modifiable before, during or after pregnancy. Narrative Infants born preterm are at high risk of infant death and of serious complications that carry a high cost to society. Women with a history of preterm delivery may also be at risk of cardiovascular disease (CVD) in later life. Preterm delivery and/or later CVD may be preventable by screening for CVD risk factors, many of which (e.g. high lipid levels) are potentially modifiable before, during or after pregnancy. __SpecificAimsTextDelimiter__ A. Specific Aims: Cardiovascular disease (CVD) is a leading cause of death and the largest killer of women in the United States. Preterm delivery and its short-term and long-term consequences constitute serious health problems in both the offspring and the mother. Evidence suggests that pregnancy complications, particularly pre-eclampsia, may increase risk of future CVD. Recently, linked birth and death records suggested a relation between later maternal cardiovascular mortality and a prior history of a preterm delivery. But there are limited data on whether CVD risk factors increase the likelihood of preterm delivery. It is completely unknown if some, all, or none of these risk factors persist after delivery. We propose to address this issue with data from a cohort of young, low income minority women from Camden, NJ using prospectively collected information and biological samples. The specific aims and hypotheses to be tested are: A1. Aim #1 (nested case-control study during pregnancy): To determine if biomarkers of CVD risk factors are associated with increased risk of preterm delivery. We will compare cases of preterm delivery (n=295) to the controls who were randomly selected among women with term delivery (n=885). We hypothesize a positive association between CVD risk factors/biomarkers and preterm delivery. It is possible that, as our data on free fatty acids suggest (SECTION C) cases have CVD risk factors that develop with gestation (by week 28) seemingly provoked by the pregnancy. Another possibility is that abnormal levels of CVD risk factors are present from entry (<20 weeks) - if so it will not be possible to discern whether risk factors antedate the current pregnancy or arise early (<20 weeks) in its course. The expected associations include: (1) Maternal hyperlipidemia. Hyperlipidemia is a strong predictor of CVD risk. We will measure concentrations of total cholesterol, HDL- cholesterol, LDL-cholesterol, triglyceride, apolipoprotein B100 and apolipoprotein A1. (2) Circulating inflammatory biomarkers. Inflammatory marker C-reactive protein (CRP) and fibrinogen, primarily a coagulation protein and also an acute-phase reactant, are independent predictors for CVD risk. CRP is also predictive of preterm delivery. (3) Endothelial dysfunction biomarkers. Endothelial function plays a central role in vascular homeostasis and its biomarkers predict CVD risk in healthy individuals. We will measure endothelial dysfunction biomarkers including soluble intercellular adhesion molecule-1 (sICAM-1), vascular cell adhesion molecule-1 (sVCAM-1) and sE-selectin. A2. Aim #2 (nested case-control study at postpartum): To determine if biomarkers for CVD risk during pregnancy return to normal level at 6 weeks postpartum comparing cases and controls from the cohort (N=672) enrolled 1996-1999 from whom data and samples were collected during the postpartum. We will again compare cases delivering preterm (N=73) to randomly selected controls (n=219). Persistent CVD abnormalities in pregnancies complicated by a preterm delivery may presage later maternal cardiovascular morbidity and CVD mortality. We hypothesize that elevation in circulating lipids levels, inflammation and endothelial function markers will return to normal level in the controls, whereas the biomarkers will remain abnormal in the cases. The unique aspects of this proposal are: 1. This study will use novel biomarkers and a rich database (with over 1800 variables per subject including known risk factors for preterm delivery including cigarette smoking, prior history of preterm delivery, ethnicity and maternal adiposity measures) obtained prospectively from a high risk population of young, low income minority women. 2. Whether preterm delivery is a pre-CVD state is unknown. We will examine if altered levels of biomarkers for CVD risk arise during pregnancy and return to normal at 6 weeks postpartum when cases are compared to controls. 3. The resources to conduct the study are readily available and can be utilized in a very cost-effective manner because the data and blood samples have already been collected. 4. We will be able to evaluate the predictive power of changes in the selected biomarkers longitudinally because we have collected specimens at entry to prenatal care (<20 weeks) and later (28 weeks) in gestation and in the postpartum (6 weeks).